Research training in infection and neurodevelopment in Uganda

Project Summary/Abstract
Infectious diseases are the most common cause of illness in children in low-income countries. Children who
survive infectious diseases often suffer long-term neurodevelopmental morbidity, but the neurologic, cognitive
and developmental consequences of infections in children remain understudied. In this renewal application, we
focus on training in the epidemiology and pathogenesis of infection-related brain injury and
neurodevelopmental impairment in children, a neglected training area in infectious disease. Innovative aspects
of this proposal include: the emphasis on infection-related long-term morbidity, a diverse mix of trainees from
multiple disciplines working toward collaborative research, core training that brings together the diverse
trainees, development of a post-doctoral “pipeline” for faculty positions, and training in essential research
support areas, including bioethics, data science and research administration. The proposed training will
produce a team of research and public health leaders who can work together to define, prevent and treat
infection-related neurodevelopmental impairment. The goal of this application is to establish a core of Ugandan
researchers who advance the understanding, prevention and treatment of long-term neurocognitive disability
associated with infectious diseases. We propose to accomplish this goal through training: 1) doctoral students
in immunology, epidemiology, biostatistics and pediatric infectious diseases; 2) post-doctoral fellows in
epidemiology, neuropsychology, pediatric neurology and pediatric neuroradiology; and 3) Master’s students in
clinical trials, and in the research support areas of bioethics, data science and research administration. The
Makerere University/Indiana University Center for Infection and Neurodevelopment in Jinja, Uganda, with
sophisticated clinical, data science, laboratory and neuroimaging capacity, will provide an ideal base for trainee
and graduate research studies in infection and neurodevelopment. The proposed training will result in a
significant increase in research capacity and public health leaders who can work together to understand,
prevent and treat infection-related neurodevelopmental impairment.

Public health relevance
Project Narrative In low-income countries, many children who have infections not only suffer the short-term effects of the infection, but also develop long-term brain injury that affects functions like intelligence, language, speech and movement. Training doctors and scientists to discover how often this occurs and why it occurs, and to treat or prevent the problem, could improve the lives of millions of children.